Development of novel anti-TB drugs that inhibit cell wall biosynthesis and respiration

ABSTRACT
Tuberculosis (TB) is the leading cause of death due to an infectious agent worldwide. The enormous mortality
rates associated with this disease are made worse by the emergence of multi-drug resistant bacteria. Thus, new
drugs to treat TB are urgently needed. Unfortunately, few new drugs and drug targets have been validated
against Mycobacterium tuberculosis (Mtb) despite considerable advances in our understanding of the
biochemistry and metabolism of this bacterium. It has become apparent that not all essential metabolic
processes represent good drug targets in bacteria. Fortunately, years of drug development efforts have revealed
a number of bacterial processes that do appear to contain good targets for antibacterials. These processes
include cell wall biosynthesis and cellular respiration. We propose to discover and develop inhibitors that target
these druggable processes. To this end, we have developed screens that broadly detect cell wall biosynthesis
and respiration inhibitors in Mtb. We have also demonstrated that our screens efficiently identify promising drug
leads that are active against Mtb and are specific to these pathways. In our existing CETR, we identified DG167,
a compound that inhibited KasA which is an essential enzyme involved in mycolic acid biosynthesis. DG167 has
cidal activity against Mtb and it also eliminates persisters in vitro when used in combination with the first line anti-
TB drug isoniazid. A CETR screen for respiration inhibitors also successfully identified DG70 and DG77. DG70
inhibited menaquinone biosynthesis, an essential component of cellular respiration in Mtb. DG70 has sterilizing
synergy with several key first and second line TB drugs and it has potent activity against persistent forms of Mtb.
Finally DG77 was confirmed to also inhibit respiration in Mtb, with the advantage that it had a very high genetic
barrier to resistance and strong sterilizing activity in persistent cultures. DG167 has been successfully developed
into a highly promising lead with greatly improved PK and activity in an acute mouse model of TB infection.
Similarly, DG70 and DG77 have been improved to yield improved ADME as well as in vivo mouse efficacy. Here,
we propose to further develop these promising cell wall and respiratory leads into optimized drug leads as pre-
clinical candidates. We will also fully characterize existing and ongoing hits from our screens, and optimize the
most promising of these into additional leads through our pipeline. Our three specific aims are: 1) Hit to lead and
lead optimization of our DG167 analogs that target cell wall biosynthesis in Mtb. 2) Explore and optimize the anti-
tubercular drug properties of our DG70 and DG77 compound series that inhibit respiration in Mtb. 3) Evaluate
and develop our novel compounds that inhibit cell wall biosynthesis and respiration in Mtb, discovered through
our PiniBAC, Pcyd and Pnark2 screens. Together, these three aims will discover, characterize and optimize a variety
of compounds with novel targets that inhibit critical pathways in Mtb and greatly advance and accelerate the
currently thin pre-clinical pipeline of anti-tuberculars with novel chemical series and new mechanisms of action.

Public health relevance
NARRATIVE This proposal will develop new therapies that will help to cure even the most drug resistant forms of tuberculosis. It will also have the potential to reduce the length of time need to treat tuberculosis and stop new resistance from happening. If achieved, our new therapy would be an important step towards the global eradication of tuberculosis.